PROCESS DEVELOPMENT OF TELACEBEC FOR TUBERCULOSIS

The overall objective of this project is for the contractor to support the chemistry, manufacturing, and controls (CMC) development of Telacebec (Q203), to treat Tuberculosis.

Rare Diseases